ILEAL CONTROL OF GASTROINTESTINAL TRANSIT AFTER ILEAL POUCH AND ANASTOMOSIS

The effects of ileal pouch manipulation on gastric emptying, small bowel transit time, stool volume, and gastrointestinal peptides will be determined in this study.